Biostatistics and Bioinformatics Core

Project Summary/Abstract The overall goal of the Biostatistics/Bioinformatics Core (Core B) is to provide state-­of-­the-­art biostatistics and bioinformatics support to ensure the rigor of the science and operations within the Cervical SPORE by participating fully in the design of preclinical studies and clinical trials, validation of assays and data systems, quality control of data and specimen management, and the statistical analysis, interpretation, presentation and sharing of data by consultation and collaboration throughout our infrastructure at the Johns Hopkins University (JHU), University of Alabama at Birmingham (UAB), and the University of Colorado at Boulder. Core B will provide centralized biostatistical and bioinformatics services as well as collaborative research and data management support for the research projects of the SPORE. Core B will serve as the focal point from which the SPORE investigators, including developmental pilot project and career enhancement program awardees, to draw upon statistical expertise for their research projects. The Specific Aims of Core B are to (1) provide biostatistics and bioinformatics consultation and support by assisting in experimental design and data collection, visualization, analysis, quantitative modeling, interpretation, and publication for all SPORE projects;? (2) provide biostatistics and bioinformatics support for the Tissue/Pathology/Immunology Core (Core C), the Developmental Research Program (DEP) awardees, and the Career Enhancement Program (CEP) awardees;? and (3) to develop new or adapt existing biostatistics and bioinformatics methods as needed and appropriate. Core B will also provide assistance with the identification and solution of complex database tasks arising in the course of project activities. This includes integration of clinical and basic research databases and interfaces for data entry, data retrieval, patient or sample tracking, and procedures to ensure data quality, integrity, and confidentiality. This web-­based database will provide a centralized means to produce interim reports of projected progress, patient accrual, processing of specimens, completeness of data gathering, and monitoring of patient drop out or loss to follow-­up. Core B is led by Drs. Chenguang Wang, Ph.D. (JHU), Sejong Bae, Ph.D. (UAB), and Anne Rositch, M.S.P.H., Ph.D. (JHU), and further supported by co-­investigator Dr. Sarah Wheelan, M.D., Ph.D. (JHU). All projects, including those within the CEP and DRP, and other cores of the SPORE will be supported by Core B.

Public health relevance
Project Narrative The Biostatistics/Bioinformatics Core (Core B) will provide state- of- the- art biostatistics and bioinformatics support to ensure the rigor of the science and operations within the Cervical SPORE by participating fully in the design of preclinical studies and clinical trials, validation of assays and data systems, quality control of data and specimen management, and the statistical analysis, interpretation, presentation and sharing of data by consultation and collaboration throughout our infrastructure at the Johns Hopkins University, University of Alabama at Birmingham, and the University of Colorado at Boulder.